Addressing Rural Disparities in Food and Nutrition Security and Cardiovascular Diseases Through Access to Emergency Food for Older Adults

PROJECT SUMMARY/ABSTRACT
Older adults in rural communities experience disparities in food and nutrition security and cardiovascular
disease outcomes. Enhancing access to healthy food through the emergency food system (food pantries, food
banks, and other direct food aid organizations) has the potential to improve dietary intake for low-income older
adults, enhance food and nutrition security, and serve as a prevention measure for cardiovascular diseases,
but this resource is underutilized by older adults. Thus, aligned with the Strategic Plan for NIH Nutrition
Research’s focus on promotion of healthy aging through nutrition, research is critically needed to understand
how to effectively encourage older adults to use the emergency food system. In the proposed project, Dr.
Brady, a mixed-methods researcher, will collaboratively work with stakeholders in the emergency food system
and older adults to co-produce research on barriers and facilitators to access and develop an intervention to
connect older adults to food pantries in their communities. With a diverse mentorship team and the resources
available through the University of Minnesota, this Pathway to Independence Award will support Dr. Brady in
filling critical gaps in his training in community engaged research, the intervention development process from
conception to dissemination, and dietary assessment to begin his career as an independent investigator
working with communities to co-produce solutions to food and nutrition security and diet-related chronic
disease. To prepare for this role, Dr. Brady will complete a comprehensive training plan including coursework,
mentorship, engagement, and research in (1) applied expertise in community-engaged research, (2)
intervention development, testing, implementation, and dissemination, and (3) dietary and nutrition assessment
methods. This training will prepare Dr. Brady to conduct the proposed research. During the mentored K99
phase, he will identify barriers and facilitators to emergency food access for older adults in rural communities in
a mixed methods study using a community engaged approach (Aim 1). In the independent R00 phase, Dr.
Brady will use human centered design approaches to co-develop intervention strategies to increase access to
emergency foods with older adults and stakeholders in the emergency food system (Aim 2). Finally, he will test
this intervention in a preliminary study to assess the feasibility, acceptability, and potential to improve food and
nutrition security, dietary intake and cardiovascular disease outcomes (Aim 3). The findings from this proposed
research will be used as the foundation for an intervention study examining the effectiveness of these
strategies to improve dietary intake and cardiovascular disease outcomes through enhancing food and nutrition
security and facilitate Dr. Brady’s transition to a successful, independent research career.

Public health relevance
Project Narrative Older adults in rural communities disproportionately experience food and nutrition insecurity, which may contribute to urban/rural disparities in cardiovascular disease outcomes. The emergency food system, particularly food pantries, serve as a safety net for rural older adults who are ineligible for or underserved by government food assistance programs, but there are barriers to accessing this resource and it is particularly underutilized by older adults and in non-metropolitan areas. By co-producing research with stakeholders in the emergency food system and rural older adults, findings from this proposed project will inform interventions in the emergency food system to enhance food and nutrition security, improve dietary intake, and benefit rural older adults with cardiovascular disease.